Core C

CORE C: RECRUITMENT, RETENTION AND COHORT MANAGEMENT
ABSTRACT
The Recruitment, Retention and Cohort Management Core will coordinate all aspects of creating and maintaining
an enrolled Longitudinal Study Population of 10,000 dogs. In this complex nationwide study, effective
communication with owners and veterinarians is paramount to facilitate accurate and timely submission of data
in many forms. To ensure success, this core will be governed by the Chief Veterinary Officer, Dr. Kate Creevy,
at Texas A&M College of Veterinary Medicine & Biomedical Sciences, along with Dr. Audrey Ruple from Purdue
University College of Veterinary Medicine, Dr. Daniel Promislow, the PI of the U19 Research Program, and Dr.
Marta Castelhano from Cornell University College of Veterinary Medicine. The Recruitment, Retention and
Cohort Management Core will achieve its overall goals through a set of four specific aims. Specific Aim 1 will
enroll, manage and maintain a cohort with sufficient power to address the central hypotheses of the U19 including
crafting a balance of dog breed, sex and age for the study segments, and representing the diversity of dog
owners in the United States. Core C will create and distribute recruitment materials to veterinarians and dog
owners; will coordinate enrollment requests and select participants; and will ensure Informed Consent is obtained
from owners and archived. Through this Competing Revision, Specific Aim 2 will create a sustainable biobank
that will serve both the DAP and researchers outside this project by making biospecimens from the well-
characterized DAP cohorts available for new investigations over time. Specific Aim 3 will establish and maintain
protocols to facilitate efficient collection, tracking and processing of biospecimens and data with minimal burden
on participants. Core C will monitor timely completion of study-related physical examinations, questionnaires and
laboratory assessments and submission of data generated by these events. Finally, Specific Aim 4 will create
the infrastructure needed to respond to questions and concerns from participating owners and veterinarians
regarding completion of study-related tasks, and to oversee ongoing communication with and among participants.